Mechanisms of folate action during nervous system development

Abstract
Supplementation with the vitamin B9, folate, during pregnancy reduces the incidence of neural tube defects
(NTDs), one of the most common and serious birth defects diagnosed in human fetuses and newborns. NTDs
result from the failure of neural tube closure during early fetal development, which potentially exposes the neural
tissue to a toxic environment and mechanical trauma, resulting in neural tissue degeneration and severe
neurological consequences, including fetus and newborn death. Under the previous funding period we made a
paradigm-shifting discovery, that the rescue by folate of folate receptor 1 (FOLR1) deficiency-induced NTD
phenotype in Xenopus laevis embryos and in human induced pluripotent stem cell (hiPSC)-derived neural
organoids is independent of folate participation in metabolism. Instead, we find that FOLR1 regulates apical
endocytosis and adherens junction molecule turnover by counteracting the action of the interacting protein CD2-
Associated Protein (CD2AP), that we discovered through interactomic studies. The concerted actions of both
FOLR1 and CD2AP are important for neural plate cell apical constriction and neural plate folding. The molecular
signature of the signaling pathway recruited by folate/FOLR1 during neural tube formation demands further
investigation.
We will follow up on the discoveries from our previous investigation and preliminary results by interrogating the
signaling partners and mechanisms underlying folate/FOLR1 action through candidate and unbiased screening
approaches. We will focus on folate/FOLR1 regulation of Ca2+ dynamics in the neural plate during folding. We
will investigate the potential interaction between FOLR1, and prohibitins, a family of scaffold proteins that serve
as signaling hubs, by discovering their role in regulating apical endocytosis and adherens junction remodeling
by using Xenopus laevis embryos and hiPSC-derived neural organoids as model systems.
Identifying the signaling mechanisms that mediate folate/FOLR1 action during neural tube formation may
contribute to defining risk groups and treatment of folate insensitive and sensitive NTDs, as well as potential
unintended consequences of folate supplementation. In addition, the findings resulting from this investigation will
contribute to other fields of research including cancer, neurodegenerative diseases, neurogenesis and neuronal
differentiation, to name a few, given the prominence of signaling molecules being studied and the potential for
identifying further novel interactors of these molecules.

Public health relevance
Project Narrative Neural tube defects are one of the most serious and common birth defects that occur when the neural tube fails to form and close, leading to in utero fetal lethality or devastating neurological consequences in affected infants. The causes of these defects are unclear but folate have been identified as beneficial in preventing the occurrence of neural tube defects. The overall goal of this research program is to discover the signaling mechanisms underlying folate action during neural tube formation to enable the development of therapeutic and preventative strategies against neural tube defects.